Hunger-dependent modulation of neural circuits for social visuomotor processing in schooling fish

PROJECT SUMMARY
The continuous influx and prioritization of particular aspects of sensory information into the nervous system is
fundamental for interaction with the environment. The brain must dynamically modulate neural representations
of and behavioral responses to relevant sensory stimuli depending on an organism’s internal state. This flexibility
can drive important changes in behavior, subsequently conferring evolutionary advantages and balances to
homeostatic needs (e.g., a small fish might benefit from heightened sensitivity to food-relevant sensory cues
when hungry, enhancing its ability to detect small prey-like organisms). Collective behavior, such as the
coordinated movement of a school of fish, is thought to confer a selective advantage, helping the group perform
behaviors such as food-seeking more effectively. How does an animal group synchronize its behavior based on
the internal states of individual members? Relatively little is known about the neural circuits processing the
social motion of conspecifics and how they may be modulated by an internal state, such as hunger. To better
understand how internal states influence complex natural sensorimotor behaviors, this project will investigate
the neural circuits involved in hunger-dependent perception of social motion in schooling fish. To accomplish
this, the small and transparent micro glassfish (Danionella cerebrum) will be used, a new model system in
neuroscience with genetic amenability, lifelong optical transparency, and innate engagement in coordinated
schooling behavior. Previous work in the Lovett-Barron lab has indicated that adult D. cerebrum engage in
schooling using vision alone, providing a unique opportunity to investigate the brain-wide networks that underlie
hunger-dependent social motion perception using a visual virtual reality system and simultaneous brain-wide,
cellular-resolution two-photon calcium imaging in behaving adult fish. In addition, multi-animal posture
tracking and pharmacological perturbation will be used to quantify complex group behavior and probe the
involvement of specific brain areas to state-dependent behavior. This project will identify the neural populations
involved with the perception of and response to group social motion across the brain and investigate how those
circuits are modulated by hunger. Then, targeted pharmacological perturbation of hunger-producing neurons
will be used to reveal how this population influences the sensory representation of social motion. Understanding
how the brain responds to hunger cues and regulates sensory processing is critical for comprehending the
complex interplay between appetite regulation and sensory perception. By leveraging insights from evolutionary
conserved neural circuits, this research has the potential to uncover fundamental principles applicable to diverse
vertebrate species, including humans, paving the way for novel strategies to address obesity and malnutrition on
a broader scale.

Public health relevance
PROJECT NARRATIVE The brain's ability to adjust sensitivity to sensory stimuli based on an animal’s internal state is crucial for interactions with the environment. To explore how internal states influence complex natural sensorimotor behaviors, this project will employ a multidisciplinary approach to investigate the hunger-dependent perception of collective social motion in schooling fish. This research will offer insights on the intricate interplay between sensory perception and appetite regulation in evolutionarily conserved neural circuits, potentially informing new strategies to address obesity and malnutrition across diverse vertebrate species.